Mechanistic Study of Methotrexate-Induced Oxidative Distress in Neurons and the CSF

PROJECT SUMMARY
The neurocognitive side effects of cancer chemotherapy in pediatric patients are heart-breaking; not only must
these children deal with the hardship of the disease and harsh treatment, but they often also face
neurocognitive impairments that affect their performance in school and their daily life as cancer survivors.
These brain toxicities, named “chemobrain”, or Chemotherapy-related Cognitive Impairment (CRCI), include
immediate symptoms (confusion, memory impairment, ataxia), as well as prolonged neurocognitive
malfunctions. THE GAP IN THE FIELD: Not enough is known about the molecular mechanisms of
chemotherapy-induced toxicity. Specifically, metabolic aberrations in the brain that ensue following therapy
with metabolic drugs such as the anti-folate MTX, a standard of care for childhood leukemia, is an unexplored
field. To be able to offer solutions to chemotherapy-induced neurotoxicity it is critical to first understand the
molecular mechanisms of the toxicity caused by common chemotherapies. Therefore, THE GOAL OF THIS
PROJECT is to elucidate targetable mechanisms that mediate and modify chemotherapy-induced neurotoxicity
with focus on oxidative distress. HYPOTHESIS: A good understanding of the molecular mechanisms of CRCI
is required to be able to offer preventive care or treatment. PRELIMINARY DATA: We applied metabolite
profiling of MTX-treated mouse and human cerebrospinal fluid (CSF) to study the metabolic impact of the drug
and revealed oxidative distress in the CSF and the choroid plexus (ChP), the organ that produces the CSF. We
found that in addition to damaging the ChP and CSF, MTX also caused toxicity to neurons in the hippocampus.
However, these findings offer some hope: the CSF can serve as a conduit for therapy because it is relatively
accessible for clinical intervention and reaches all parts of the brain. Indeed, our discovery that MTX treatment
causes reduction in CSF levels of the secreted antioxidant enzyme SOD3, both in mice and in MTX-treated
patients, led us to test CSF-based therapy; ChP-targeted gene therapy with exogenous SOD3 expression
replenishes CSF's protective capacity, preventing metabolic damage in the hippocampus and even rescues
MTX-induced behavioral deficits in mice. APPROACH: We will test our hypothesis that the ChP-CSF system
can be harnessed to alter the brain redox environment to reduce adverse effects of chemotherapy on non-
cancerous brain cells by assessing the mechanisms by which CSF-SOD3 protects the hippocampus from
MTX-induced toxicity (Aim 1), by studying the role of nitric oxide (NO) and peroxynitrite in the MTX-induced
oxidative damage in ChP cells and neurons (Aim 2), and by testing if resuming oxidative balance in the CSF
can be achieved by peripheral and brain-specific injection of antioxidants, and whether these are sufficient to
mitigate oxidative damage to ChP and hippocampus (Aim 3). IMPACT: Our study will reveal actionable tools
to mitigate the neurological damage induced by MTX, and other chemotherapies, and the immediate potential
of antioxidants co-administration with chemotherapy for amelioration of CRCI and improved survivorship.

Public health relevance
PROJECT NARRATIVE Chemotherapy is a cornerstone of modern cancer therapy, yet it also damages healthy cells in the brain. Here, we combine cutting edge metabolite profiling, chemical detection methods, and genetic approaches to study the molecular mechanisms by which the chemotherapy methotrexate leads to oxidative distress in the choroid plexus, cerebrospinal fluid, and hippocampus. These experiments represent a critical new direction of investigation into how a current limitation of cancer chemotherapy can be reduced or prevented in the brain by leveraging CSF-based solutions.